Infrastructure and Opportunity Fund Management Core

IOFM Core: Infrastructure and Opportunities Management Core
Project Summary
The NIH Cooperative Centers on Human Immunology (CCHI) program was designed to promote research in
human immunology by providing funding for 8-10 Programs as well as additional financial support for pilot
projects, new resource and reagent development and/or cross-program collaborative efforts. These
developmental awards are made possible through funding provided by the Infrastructure and Opportunity Fund
(IOF) grant. The Infrastructure and Opportunity Fund grant is awarded to one of the Programs supported
through the CCHI U19 mechanism. The institution that receives the Infrastructure and Opportunity Funds grant
is responsible for establishing an Infrastructure and Opportunity Fund Management Core (IOFMC). The
IOFMC works with the NIH Program officers and the CCHI scientific steering committee to solicit, review and
distribute Infrastructure and Opportunity Funds as subawards to researchers at the IOFMC parent institution
and investigators working at other institutions, who are, in many cases, members of one of the other funded
CCHI cooperative centers. The IOFMC is responsible for administrative oversight of the subawards and for
ensuring that the recipient of the award and the institution in which they work are in compliance with all
applicable state, NIH and federal regulations and that charges to the subaward are reasonable and allowable.
Finally, the IOFMC must also provide annual financial reports on the awarded subcontracts to NIH. The major
goal of the UAB IOFMC will be to establish an administrative structure that will manage the subaward program
from the request for applications (RFA) stage, to the pre- and post-award process, and through the grant close-
out and reporting phase. In order to meet this goal, we will: (i) coordinate the IOF project application and
selection process; (ii) establish subcontracts to distribute IOF development and pilot project grants to Project
Leaders at other institutions; (iii) provide administrative and fiscal oversight of these subawards; and (iv) serve
as the communications interface between IOF awardees, the CCHI steering committee and the NIH.
Successful and timely completion of these objectives by the UAB IOFMC will allow the NIH to leverage the
intellectual, infrastructure and unique reagents/samples that are present in the CCHI network institutions to
advance the overall scientific goals of the CCHI program.